Prevalence and temporal dynamics of clonal mutations associated with the risk of hematological cancer in a cohort of clinically healthy Nigerians

PROJECT SUMMARY/ABSTRACT
The burden of non-communicable diseases, especially hematological malignancies and cardiovascular diseases
(CVDs), is rising in Africa. Clonal Hematopoiesis of Indeterminate Potential (CHIP) is an age-related risk factor
for all-cause mortality, blood cancer and CVDs, prompting huge interests in the development of drugs targeting
CHIP mutations to intercept progression to malignancies. However, individuals of African descent are a minority
in these CHIP studies hence the need to understand the spectrum and frequency of CHIP variants in African
populations. My long-term research goal is to generate a pan-African database of somatic mutations
associated with the risk of developing myeloid leukemia. Recent genome-wide association analyses have
identified germline loci predisposing individuals to increased risk of CHIP acquisition. These include the
rs144418061 intergenic variant near TET2 found only in African-ancestry populations. The central hypothesis is
that there is a high burden of CHIP variants in normal-aging Africans compared to age-matched healthy
Caucasians. To address this, I propose the following specific aims: Aim 1 determines the frequency of CHIP
mutations in a cohort of clinically healthy Nigerians. Whole blood samples from healthy Nigerian volunteers
≥40 years will be collected and error-corrected targeted sequencing will be carried out to genotype 54 genes
known to be frequently mutated in myeloid malignancies. Aim 2 describes temporal trends and clinical
outcomes of CHIP acquisition over a three-year period. Each subject will be followed up for three years and
the temporal dynamics of CHIP clonal dominance over the period will be determined. In addition, hematological
changes correlating with the CHIP architecture will be described. It is suspected that varying behavioral and
clinical states will impact the rate of CHIP progression in different individuals. Aim 3 will determine the
inflammatory markers associated with CHIP burden in the study population. Here, Luminex-based Human
Cytokine/Chemokine assay will be adopted to tease out inflammatory signals correlating with CHIP burden. This
K43 project will generate information on CHIP mutations in normal-aging Nigerians. This aligns with the study I
am currently leading on CHIP burden in Nigerians with varying comorbidities. My career development goal of
this K43 application is to gain skills on error-corrected sequencing, variant calling as well as data analysis and
generate sufficient data for a competitive hypothesis-driven R01 submission by the fifth year of this award. This
will enable me to build research capacity for blood cancer genetics in Nigeria and establish my independence
as an Africa-based medical geneticist. My training and research activities will benefit from a strong committee of
mentors comprising established US and Africa-based researchers in hematology, population genetics,
bioinformatics and computational analysis. I will maximize my time at the Nigerian Institute of Medical Research
carrying out hematological analysis and sequencing while taking advantage of hands-on training activities,
important data science and research leadership courses available at the National Institutes of Health.

Public health relevance
PROJECT NARRATIVE Clonal hematopoiesis of indeterminate potential (CHIP) is an age-related marker of blood cancer and cardiovascular diseases. Early and pre-disease detection of rare somatic mutations associated with CHIP in clinically healthy normal-aging Nigerians is much needed as they could offer important prediction of the risk of developing hematological malignancies and provide information on potential targets of therapeutic interventions. This project will also enable me to acquire fundamental skills in error-corrected sequencing, variant analysis and data management critical for my establishment as an independent Africa-based medical geneticist.